Core--Imaging

The Imaging Core will provide a broad spectrum of services to increase availability of brain imaging research including a) Training Series and consultation on design and implementation of new imaging research protocols, b) central data management tools for image data, c) access to automated and semi-automated processing routines for both PET and MR data, and d) ssistance in the validation and propagation of new imaging techniques as they are developed, including those in diffusion-tensor imaging, diffusion-tensor tracking, and MRS.